PAGES: Physical Activity Genomics, Epigenomics/transcriptomics Site

Project Summary
Physical activity (PA) prevents or ameliorates a large number of diseases, and inactivity is the 4th leading
global mortality risk factor. The molecular mechanisms responsible for the diverse benefits of PA are not well
understood. The Molecular Transducers of Physical Activity Consortium (MoTrPAC) is being formed to
advance knowledge in this area. We propose to establish PAGES, a Physical Activity Genomics,
Epigenomics/transcriptomics Site as an integral component of the MoTrPAC. PAGES will conduct
comprehensive analyses of the rat and human PA intervention MoTrPAC samples, contribute these data to
public databases, help identify candidate molecular transducers of PA and elucidate new PA response
mechanisms, and help develop predictive models of the individual response to PA. PAGES assay sites at
Icahn School of Medicine at Mount Sinai, New York Genome Center and Broad Institute provide the
infrastructure, expertise and experience to support this large scale, comprehensive analysis of molecular
changes associated with PA. PAGES aims are to 1. Work with the MoTrPAC Steering Committee in Year 1 to
finalize plans and protocols; 2. Perform assays and analyses to help Identify candidate molecular transducers
of the response to PA in rat models and the pathways responsible for model differences, including high-depth
RNA-seq and Whole Genome Bisulfite Sequencing (WGBS), supplemented by additional assay types such as
ChIP-seq, ATAC-seq based on initial results; 3. Perform comprehensive assays and analyses of the human
MoTrPAC clinical study tissue samples, including RNA-seq, WGBS, H3K27ac ChIP-seq, ATAC-seq and whole
genome sequencing. 4. Collaborate with the MoTrPAC to analyze data from PAGES and other MoTrPAC
analysis sites to identify candidate PA transducers and molecular mechanisms, and to develop predictive
models of PA capacity and response to training. The success of PAGES and the MoTrPAC program will
transform insight into the molecular networks that transduce PA into health, create an unparalleled
comprehensive public PA data resource, and can provide the foundation for profound advances in the
prevention and treatment of many major human diseases.

Public health relevance
Project Narrative While physical activity prevents or improves a large number of diseases, the chemical changes that occur in the body and lead to better health are not well known. As a part of a consortium of physical activity research programs working together, we will use cutting-edge approaches to comprehensively study the changes in genes and gene products caused by physical activity. This study has the potential to lead to advances in the prevention and treatment of many diseases.